Targeted Prevention of Human Ehrlichiosis

The incidence of tick-borne diseases has risen dramatically in the past two decades, and continues to rise.
Human monocytic ehrlichiosis caused by Ehrlichia chaffeensis (Ech) is one of the most prevalent, life-
threatening, emerging tick-borne zoonoses in the US. Ech is an obligatory intracellular bacterium of the order
Rickettsiales. Therapy of choice is the broad-spectrum antibiotic doxycycline, which is effective only if initiated
early. Currently there is no FDA-approved vaccine for Ech. Our long-term goal is to develop an evidence-
based vaccine approach to effectively protect humans by targeting multiple critical steps of the rickettsial
infection cycle. Toward this goal, we identified four Ech surface-exposed proteins that have known functions
required for Ech survival, and that also lack homology to human proteins, OMP-1/P28, Entry triggering protein
of Ehrlichia (EtpE), and VirB2. OMP-1/P28s are immunodominant surface-exposed outer membrane proteins
that have porin activity essential for bacterial nutrient acquisition. P28 and OMP-1B are predominantly
expressed in mammals and ticks, respectively. EtpE is an invasin that uses its C-terminus (EtpE-C) to bind the
host cell receptor to trigger Ech entry. We have shown that the type IV secretion system (T4SS) is essential for
Ech survival within the host cell. VirB2 is a T4SS pilus protein that is part of the T4SS machinery. Immunization
of mice with recombinant P28, EtpE, or VirB2 proteins generated Ech-specific antibody responses that
prevented Ech infection. These data support our premise that these proteins serve as rational vaccine
candidates for targeting non-overlapping processes in Ech infection of mammalian host cells. DNA vaccines
offer a number of potential advantages over traditional vaccines, including the stimulation of both humoral and
T-cell-mediated responses, improved vaccine stability, the absence of any infectious agent, and the relative
ease of packaging multi-components and large-scale manufacture. We showed the feasibility of an Ech DNA
vaccine in dogs by safely immunizing dogs with the DNA vaccines by percutaneous needle-free jet injection
and demonstrating humoral and cell-mediated immune responses to the DNA vaccines. Our hypothesis is
immunization with plasmid DNA vaccine encoding P28, OMP-1B, EtpE and VirB2 singly or in combination
prevents Ech transmission from ticks to mammals. To test this hypothesis, our Specific Aims are: 1. To
construct DNA vaccines encoding P28, OMP-1B, EtpE-C, and VirB2, determine the development of humoral
and cell-mediated immune responses in immunized mice, and evaluate protection of immunized mice from
infection with Ech cultured in tick cells. 2. To test if immunization of dogs with P28, OMP-1B, EtpE-C and VirB2
can prevent Ech transmission from infected ticks. The immediate outcomes of the proposed studies will be to
provide proof-of-principle for a DNA vaccine approach to the Ech vaccine candidates for blocking of Ech
transmission from ticks to dogs. The long-term outcome will be development of an anti-infective vaccine
against HME in humans that does not cause adverse effects.

Public health relevance
Project Narrative Importance to public health: The purpose of this project is to develop a vaccine to prevent an emerging infectious disease, human monocytic ehrlichiosis by blocking transmission of Ehrlichia chaffeensis from ticks to mammals. Ultimately, our findings are expected to reveal rational combinations of vaccine candidates and delivery methods for tick-borne pathogens that could serve as relevant scientific direction for future prophylactic discovery; however, what is learned will contribute to a broader understanding of formulation and delivery methods of vaccines for tick-borne pathogens. Relevance to NIH’s mission: our work pertains to developing fundamental and translational knowledge that will reduce the burden of human disability.